Illuminating Notch receptor-ligand selectivity through structure-guided protein engineering

PROJECT SUMMARY
Overall vision of the research program. My lab uses structure-guided engineering to reprogram receptor
signaling for biomedical applications. By exploring the structural biology of cell surface receptors, our goal is to
uncover novel strategies for engineering customizable signaling outputs. My research program largely focuses
on receptor families that influence the development or maturation of stem cells. The Notch signaling pathway
controls several aspects of stem cell and immune cell development, and my team has spent several years
illuminating the structural biology of Notch signaling complexes. Additionally, we are developing several tools to
turn Notch signaling “on” or “off” in desired tissues. We have also expanded our structural studies to include
proteins that mediate crosstalk between developmental signaling pathways and complexes between emerging
immune inhibitory receptors and their ligands.
Overview of research in the laboratory. Our current research is focused on two major areas. The first is the
development of biotechnological toolkits that can fine-tune receptor signaling depending on cellular context.
Using the Notch pathway as a model system, we are establishing design principles for tissue-specific activators
or inhibitors of receptor signaling. For the second area, we are studying the molecular basis for crosstalk between
developmental signaling pathways. We have identified multiple non-canonical ligands of Notch and TGF-β family
receptors that regulate signaling through both pathways. Our structure-function studies of these complex
regulatory networks will expand our understanding of developmental signaling and illuminate new opportunities
for therapeutic intervention.
Goals for the next five years. Our goals are to: (i) assess the ability of Notch-modulating biologics to influence
immune and stem cell biology in various biological systems; (ii) elucidate the molecular mechanisms by which
non-canonical Notch ligands regulate developmental signaling; and (iii) identify novel extracellular Notch binding
partners and determine their effect on Notch signaling activity. These research areas will provide a strong
foundation for our continued research in developmental signaling, which will enable us to engineer novel
biotechnologies for regenerative medicine and therapeutic development.

Public health relevance
PROJECT NARRATIVE Notch signaling guides cell fate decisions and influences the pathogenesis of inherited and acquired human diseases. In this R35 proposal, we will integrate synthetic, structural, and cellular biology to determine how emerging classes of extracellular regulatory proteins mediate crosstalk between Notch and other major developmental pathways. Additionally, we will engineer protein biologics that can modulate the activity of mechanosensitive Notch proteins for applications in regenerative medicine.